Post-baccalaureate Training in Biomedical Research

The goal of the Mayo Clinic Post-Baccalaureate Research Education Program (PREP) is to increase
the number of individuals from underrepresented groups who choose biomedical research careers.
We are motivated by the concept that a diverse research environment fosters more innovative research
than a homogeneous environment. Many training programs seek to enhance the diversity of the biomedical
research workforce. However, few of these programs emphasize the translational research linkage between
basic science and improved health. Biomedical research training programs for diverse students often fail to
emphasize practical development of the leadership skills actually required for successful careers in
biomedical research. The Mayo Clinic Post-Baccalaureate Research Education Program (PREP) bridges
these two gaps by preparing learners from underrepresented (UR) groups for successful matriculation and
completion of research-intensive biomedical science PhD programs. During the next funding cycle, we will
maintain the 22-year success of our program while increasing recruitment of UR students, improving
mentorship experiences, and providing leadership skills. Indeed, 22 years of experience have guided the
optimization of these elements.
Specific aims:
Aim 1. Recruit and retain UR learners (nine total per year) into basic science or translational
research programs at Mayo Clinic while achieving a 75% matriculation rate into PhD or MD-PhD
programs. Since its origin in 2006, the Mayo PREP has recruited and trained 63 post-baccalaureate UR
learners. Forty-three (68%) matriculated into competitive PhD or MD-PhD programs. Of those students,
95% successfully completed a doctoral degree or are on track to do so. We will continue to recruit and train
learners through our proven curriculum with its focus on intensive enrichment activities toward individualized
academic and professional development. We will maintain objective program evaluation by leveraging self-
assessment tools and surveys such as the Undergraduate Research Student Self-Assessment. We will use
pre-entrance surveys to identify the needs of each learner and craft an appropriate plan to ensure timely
learner success. We will provide access to tutors and will encourage participation in Mayo Clinic’s
institutional resource groups (MERG) to assist in learner retention. We will facilitate networking by weekly
structured meetings and quarterly meetings in a social setting with graduate students and faculty from UR
groups. We hypothesize that these tactics will continue to be effective in increasing the number of UR
learners entering PhD programs.
Aim 2. Develop a pathway that cultivates successful long-term mentor-mentee relationships to
facilitate successful research careers. Individual development plans (IDPs) have been used to identify
gaps in research experiences and develop strategies for addressing these gaps. However, IDPs can be
inadequate if not accompanied by diligent follow-up with accountability and adjustments in a changing
research environment. We will therefore implement Post-baccalaureate Advisory Committees (PACs). Each
PAC will involve the research mentor, program director, and at least one UR faculty member. The PAC will
develop an individualized plan for launching the learner into a successful career. The PAC will identify and
discuss career goals, analyze experience gaps, plan educational activities, verify career milestones, and
propose approaches for addressing professional needs. This structure will emulate a graduate student
thesis advisory committee. We hypothesize that PACs will lead to improved long-term mentor-mentee
relationships that will facilitate (greater than 90%) retention of former PREP PhD graduates in biomedical
sciences research.
Aim 3. Create a platform for developing critical thinking and leadership skills outside of the
classroom and laboratory setting. In 2016 the Mayo Clinic PREP pioneered its biennial Scientific
Innovations Through Diverse Perspectives (SITDP) conference, completely organized by students to
promote development of practical leadership skills not taught in the classroom or laboratory. The pilot was
so successful that it has now been adopted by multiple institutions. We will continue to develop this
successful platform that develops teamwork, teaching learners to work together with diverse individuals who
have different objectives, points of view, and personalities. This platform provides opportunities to broaden
professional networks, and discuss career paths with leaders in academia, industry, law, science policy,
science writing, and other fields. We will also encourage learners to participate in Mayo Graduate School’s
entrepreneurial course involving individuals from different academic, cultural, and ethnic backgrounds to
develop a product that can be used to change the life of a patient population. We hypothesize that exposure
to these opportunities will lead to the development of critical skills for becoming leaders in the biomedical
sciences.

Public health relevance
Narrative: Post-Baccalaureate Training in Biomedical Research This research education program will provide 1 or 2 years of support and professional skills development for recent college graduates. The goal is to help students from diverse backgrounds (e.g. ethnic/racial minorities, individuals with disabilities, and individuals from disadvantaged backgrounds) to advance to successful biomedical research careers at the PhD level, thus contributing to the diversification of the biomedical research workforce.